Demography Center

Project Summary
The Center for Studies in Demography & Ecology (CSDE) requests renewal of its five-year research center
infrastructure award (P2C). CSDE is a community of faculty, research scientists and students associated to
advance population science through research and training. CSDE scientists develop new demographic
measures and methods and advance knowledge about population dynamics and population health. CSDE
aims to advance the scientific understanding of human population processes, especially as they relate to five
Primary Research Areas (PRA): (1) Demographic Measurements and Methods, (2) Environments and
Populations, (3) Health of People and Populations, (4) Migrations and Settlements, and (5) Wellbeing of
Families and Households. Throughout the next five years, CSDE proposes an overarching initiative at the
scientific intersection of demography, data innovation, and population disparities, which should catalyze timely
and critically needed population science research and launch early stage investigators' independent research
within and across PRAs. CSDE offers an intellectual home for collaborating and learning through its weekly
seminar series, workshops, program-specific activities organized by PRA Chairs, staffing support for logistics,
real and virtual meeting space, and information sharing. CSDE provides the very best support for all aspects of
research administration from project inception to completion. CSDE advances population science through
expert consultation on every stage of science and easy access to cutting-edge facilities that place CSDE
affiliate researchers' work at the very forefront of their fields, including high performance computing, a
biodemography lab, data collaborative, and federal statistics data enclave. CSDE catalyzes population science
through: (1) opportunities and venues for intellectual exchanges and advancing affiliates' research, (2)
promotion of early career scientists' research, (3) innovative multi-investigator faculty research initiatives with
potential for high-reward results significantly advancing population science, and (4) outreach to external
affiliates at non-NIH-funded research centers. CSDE fosters novel approaches for advancing population
science through its faculty and staff whose methodological prowess includes expertise in Biodemography, Data
Science, and Demography. The UW values CSDE, providing $1,375,000 annually from the Office of Research,
College of Art and Sciences, and seven other colleges, schools, and initiatives. This support totals $6.9 million
over five years and represents an 83% increase from five years ago, reflecting UW's recognition of CSDE's
productivity, innovation, and impact.

Public health relevance
Project Narrative The population science research conducted by affiliates at the Center for Studies in Demography and Ecology (CSDE) contributes towards NICHD's mission to understand human development, improve reproductive health, enhance the lives of children and adolescents, and optimize abilities for all. CSDE scientists accomplish this through their research in demography, reproductive health, and population health. CSDE especially supports their efforts by catalyzing new research and launching early career investigators' research independence at the intersection of demography, data innovation, and population disparities.